Multi-Parametric Imaging of Systemic Cardiovascular and Cerebrovascular Health in Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) affects 6 million Americans and is projected to increase to 14 million by the year 2050,
with no effective treatment strategies. It is becoming increasingly recognized that AD is multifactorial in nature;
the most common mixed dementia pathology is AD amyloid and tau depositions in concert with cerebrovascular
disease. However, the exact role of vascular disease in relation to tissue pathology and AD pathogenesis is still
uncertain. Magnetic resonance imaging (MRI) is frequently used to observe structural brain changes in AD, but
also has the capacity to functionally assess cerebrovascular disease, including cerebral blood flow, pulsatility,
perfusion, and white matter lesions of vascular origin. Using 4D flow MRI and pseudo-continuous arterial spin
labeling (pCASL), our research group has shown that alterations in cerebrovascular flow and perfusion exist in
AD cohorts. We plan to further our vascular imaging territory by utilizing MRI to derive aortic pulse wave velocity
(PWV) measures to indirectly asses aortic stiffness, an independent predictor for systemic cardiovascular
disease. However, these acquisitions (1) typically require breath-holds to reduce respiratory motion artifacts,
which may not be possible in some aging or AD individuals and (2) require high temporal resolution to accurately
resolve flow waveforms. Aim 1 is designed to address this by developing a novel, accelerated, free-breathing
MR methodology to measure aortic PWV, providing a metric for global cardiovascular health. Specifically, we
will employ a radial simultaneous multi-slice (SMS) phase contrast sequence with through-plane encoding and
constrained reconstruction to greatly improve resolution capabilities. Aim 2 will validate obtained aortic PWV
measurements (from Aim 1) against gold-standard pressure wire measurements with in-vitro testing in 3D printed
aortic models and test repeatability of such measures in healthy volunteers. In collaboration with other members
at the UW, our research group has implemented methods to probe microvascular pulsatility using displacement
encoding stimulated echo (DENSE) sequences as well as measure cerebrovascular PWV using highly-
constrained 4D flow reconstructions. Aim 3 seeks to combine cranial 4D flow, pCASL, DENSE, structural brain
imaging, and methods from Aim 1, to simultaneously assess multiscale vascular health and structural changes
in a group of AD-confirmed and healthy age- and sex-matched controls. This would be the first study to bring
together these advanced quantitative MR imaging techniques, providing new insights into vascular disease
amongst those with and without AD as well as knowledge of how vascular disease relates to structural changes.
Completion of the proposed project and training plan will expand the academic scope of the applicant and foster
his goals of becoming an independent investigator focused on translational imaging research.

Public health relevance
PROJECT NARRATIVE The overarching goal of this work is to help elucidate the role that the vascular system plays in the pathogenesis and progression of Alzheimer’s disease (AD), a disease that currently has no forms of treatment. This proposal aims to develop and validate a new MR imaging approach to measure the pulse wave velocity of blood flow in the aorta, a biomarker for vascular disease, in patients with AD. This technique will be used together with additional MRI measurements of cerebrovascular health to better understand the impact of systemic versus cerebrovascular specific disease on AD pathology and neurocognition, as well as observed structural brain changes.